Childhood follow-up study of obesity and neurodevelopment after perinatal exposure to adjunctive azithromycin prophylaxis for cesarean delivery

PROJECT SUMMARY/ABSTRACT
We propose a large multi-center non-inferiority follow-up cohort study designed to evaluate long-term
obesity/growth and neurodevelopment after perinatal exposure to adjunctive azithromycin as compared with
placebo (plus standard cephalosporin) to prevent surgical site infections at cesarean delivery. The parent
C/SOAP randomized trial of adjunctive azithromycin (4/2011–11/2014) demonstrated a significant reduction in
maternal infections (endometritis and wound infection) without any significant effect on short-term neonatal
outcomes in the azithromycin group. This reduction in maternal infection (a major cause of death) was so
significant that azithromycin use was found to be cost-saving – saving ~$360/unscheduled cesarean and $270
million/year in US healthcare costs. However, enthusiasm for adjunctive azithromycin has been tempered
given reports of changes induced by azithromycin on the newborn gut microbiome that may be associated with
childhood weight gain/obesity and neurodevelopmental impairment. In September 2018, ACOG suggested
“consideration” of adjunctive azithromycin, but emphasized the need for studies of its effect on long-term
childhood outcomes. In response to these concerns, we proposed an R01 study evaluating pulmonary and
gastrointestinal (GI) health after perinatal azithromycin exposure (6th percentile score). Reviewers emphasized
the need to evaluate obesity/growth and neurodevelopment (NIH officers advised a separate application due to
cap limitations). Thus, in this proposal, we hypothesize that perinatal exposure to adjunctive azithromycin
compared to standard cesarean prophylaxis alone is not associated with increased risk of obesity/weight gain
or neurodevelopmental impairment (i.e. is non-inferior). We propose a follow-up study of the offspring of the
C/SOAP trial cohort at target age of 7 years (range 6-9) at the 14 sites in the parent trial. We expect at least
1410 of 2013 children (70% follow-up) whose mothers were enrolled in C/SOAP will undergo a single study
visit incorporating growth/biometry and neurodevelopment assessments to address the following specific aims:
1) To compare the incidence of obese/overweight children (primary outcome), and other biophysical
measurements, between cohort offspring aged 7 (range 6-9 years) after perinatal exposure to
adjunctive azithromycin versus placebo (standard prophylaxis alone)
2) To compare neurodevelopmental outcomes including cognitive ability (primary outcome), functional and
behavioral impairment, and motor proficiency, between cohorts at age 7 (range 6-9 years) after
perinatal exposure to adjunctive azithromycin versus placebo
This study, along with the companion study evaluating pulmonary and GI outcomes (award notice pending), is
the only opportunity to efficiently provide comprehensive long-term safety data from a large US trial to inform
and strengthen the newly recommended use of adjunctive azithromycin for cesarean delivery.

Public health relevance
PROJECT NARRATIVE Cesarean delivery, the most common major surgical procedure in the US, is the strongest risk factor for maternal infection (a top 3 cause of death during childbirth). Adjunctive azithromycin compared to standard antibiotic prophylaxis alone is proven (through our large C/SOAP trial and other studies) to be highly effective in preventing infection after cesarean - with authorities now recommending consideration of its use while calling for more information on long-term health outcomes after exposure at birth. We propose a US multi-center long-term follow- up study of children from the parent C/SOAP trial at age 7 (6-9) years to evaluate childhood obesity/growth and neurodevelopment after perinatal exposure to adjunctive azithromycin (complementing our NICHD grant evaluating pulmonary and gastrointestinal health scored at the 6th percentile); findings from this study will be used to inform and strengthen national and global health care policy regarding the safety of adjunctive azithromycin to reduce maternal infection after cesarean delivery.